XRAY DIFFRACTION ANALYSES OF PLANT VIRUSES

We have used synchrotron radiation for high resolution structural studies of plant viruses. Diffraction data were collected from crystals of Satellite Panicum Mosaic Virus (SPMV) leading to a 1.9 w resolution structure of the T=1 virus. Diffraction data from crystals of Turnip Yellow Mosaic Virus (TYMV), a T=3 virus with a very large unit cell, were also collected to 3.5 w resolution. These data, which are unattainable using conventional X-ray generators, are being used in the structural determination of TYMV. Plant virus structural studies are important in understanding virus structure, but also provide a convenient way to study the ways in which X-ray data collection and data processing of large unit cells can be done successfully.